Impact of alcohol reduction on Tuberculosis drug levels, TB adherence and gut microbiome

ABSTRACT
This is a request for supplement to the R01AA027972 titled “Hybrid trial for alcohol reduction among people
with TB and HIV in India (HATHI)”. The proposed study is related to the parent study aim (aim 2) that seeks to
examine the effectiveness of alcohol reduction on TB treatment outcomes. In aim 1 of this supplement, we
propose to assess whether and how the intervention affects TB drug levels during treatment. Further, as one of
the outcomes for aim 2 is TB treatment adherence, we propose to assess adherence through an objective
measures (urine INH dipstick) in addition to the subjective questionnaires already being used in HATHI. In aim
2 of the this supplement, we propose to collect blood and stool samples in order to create a biorepository. This
will allow for future studies (e.g. R01 study) that will further inform aim 2 of the parent study. More specifically,
it will help us understand whether the gut microbiome and metabolome are potential mediators between the
observed relationship between high alcohol intake and adverse TB treatment outcomes. In summary, this
study will supplement the goals of the parent study while adding valuable new avenues for assessments on
potential modifiable mediators.

Public health relevance
NARRATIVE Alcohol intake is associated with adverse Tuberculosis (TB) treatment outcomes. We propose to assess whether an alcohol reduction approach can affect factors important in TB treatment outcomes: TB drug levels, adherence to TB drugs and biological pathways related to gut microbiome and metabolism. This study will supplement the goals of the parent study, which aims to test whether reducing alcohol intake can improve treatment outcomes, while informing on the potential role of biological mediators.